Cell-type based epigenomic analysis to identify druggable genes for people living with HIV infection and using cannabis

Cannabis (CB) is frequently used by people with HIV (PWH) for its claimed benefits alongside antiretroviral
therapy. However, the immunomodulatory impact of CB in the context of the chronic inflammation experienced
among PWH is unclear. The interaction between HIV and CB in the host genome remains poorly understood.
Previous studies on the epigenetic effects of HIV and CB have been limited and most studies conducted in bulk
peripheral blood mononuclear cells (PBMCs), which only provides an average view of DNA methylation (DNAm)
changes across various cell types. Our recent research of DNAm in CD4+ T cells isolated from PWH identified
DNAm CpG sites that were linked to HIV-1 latent reservoir and a set of druggable genes, including the target for
Ibalizumab, a medication for treatment resistant of HIV infection. The result underscores the value of cell specific
DNAm analysis in uncovering mechanisms of HIV pathogenesis and potential therapeutic targets. Nonetheless,
the combined effects of HIV infection and CB use on DNAm, particularly considering genetic variants that
influence DNAm (methylation quantitative trait loci, meQTL), have yet to be fully explored. To address these
gaps, we hypothesize that CB use alters DNAm in a cell type-specific manner within the HIV-infected host, with
these changes potentially modulated by meQTL specific to each cell type. Our study aims to dissect the
epigenomic landscape of CB and HIV interaction by conducting cell-type based genome-wide DNAm and
meQTL analyses in two large cohorts of PWH, assessing their potential for druggable targets. This will
involve comprehensive profiling of DNAm across five different cell types isolated from PBMCs, alongside
functional validation studies both in vivo and in vitro. The functional validation involves transcriptome-wide
association analyses, single-nucleus RNA and ATAC sequencing to elucidate the functional impact of specific
epigenetic modifications and their relevance to drug development.
In preliminary work, we employed a computational algorithm to deconvolve DNAm data to specific cell types and
validated these findings through direct sequencing. This has revealed a more nuanced understanding of HIV's
impact at the cellular level, identifying cell type specific DNAm sites and highlighting the unique genetic
landscapes influenced by HIV across different cell populations. Furthermore, we have developed a novel
algorithm, Hierarchical Bayesian Interaction model, to uncover genetically influenced DNAm at cell type level.
These preliminary findings provide the framework for this proposed project. Our team's established expertise in
epigenomics among PWH, positions us uniquely to achieve our goal. Successful completion of this study
promises to deliver unprecedented insights into the mechanisms of CB's immunomodulatory effects in HIV,
paving the way for novel therapeutic strategies through targeted drug repositioning.

Public health relevance
The immunomodulatory impact of cannabis use in the context of the chronic inflammation experienced among people with HIV remains unclear. Previous studies on the epigenetic effects of HIV and cannabis use in heterogenous bulk cells only provide an average view of DNA methylation changes across various cell types and offer little insight into cellular epigenetic mechanism. Applying a novel computational deconvolution approach following by direct methylation sequencing validation, our goal is to identify cell-type-specific methylation aberrant sites and methylation quantitative trait loci for HIV infection and cannabis use that can be potential targets for drug repositioning.